Functional PKC Isoforms in Platelets

DESCRIPTION (provided by applicant): Protein kinase C (PKC) isoforms are serine threonine kinases that are activated upon agonist stimulation and regulate several functions. In the previous grant period, we demonstrated the functional role of nPKC isoforms in platelets and the molecular interactions of PKCδ with SHIP1 and Lyn to regulate differential granule release. We have strong preliminary data indicating that PKCδ is phosphorylated on Y155 and Y311, but these two tyrosines are differentially phosphorylated upon stimulation of Collagen or Thrombin receptors. We have generated knock-in mice for PKCδ Y155F mutation and our preliminary data point to the regulation of GPVI-mediated functional events by PKCδ through the Y155 residue. We also have strong preliminary data suggesting that Y311 might regulate cPLA2 activation and thromboxane generation. Finally, we have identified a negative regulatory role for PKCδ in megakaryopoiesis and platelet production. Hence we will focus our efforts on the molecular mechanisms of regulation of platelet function and megakaryopoiesis by PKCδ in this grant period. Our overall hypothesis is that PKCδ plays a crucial role in platelet function and megakaryopoiesis through tyrosine phosphorylation of Y155 and Y311 residues. We propose that these phosphorylated tyrosines form nodal points for signal transduction through interaction with other signaling molecules thus regulating functional responses. 1) We hypothesize that diverse signaling pathways downstream of G protein-coupled receptors and tyrosine kinase-linked receptors phosphorylate different tyrosine residues on PKCδ and these differential phosphorylations modify the functional role of this isoform. We hypothesize that PKCδ Y155 phosphorylation regulates dense granule release through association with SHIP1 and Lyn, whereas PKCδ Y311 phosphorylation regulates cPLA2 activation and thromboxane generation. We will investigate the functional role of phosphorylation of Y155 and Y311 on PKCδ in platelets using PKCδ knock-in mice with the specific mutation Y155F or Y311F. We hypothesize that phosphorylated Y155 and Y311 on PKCδ initiate different signaling pathways than other tyrosine residues on PKCδ through association of different signaling molecules and we will test this hypothesis by biochemical/proteomic approaches. 2) We hypothesize that PKCδ plays a distinct role in megakaryocyte differentiation and platelet production. We propose to test this hypothesis using bone marrow megakaryocytes from mice lacking PKCδ as well as from Y155F and Y311F knock-in mice. The studies proposed in this application will enhance our understanding of PKCδ signaling networks and their regulation of functional responses in platelets and the production of platelets. These studies will then help us identify targets to trea thrombotic disorders as well as thrombocytopenia.

Public health relevance
PUBLIC HEALTH RELEVANCE: Platelet activation is critical for hemostasis and can lead to thrombotic events. The receptor targeted by successful drugs to treat heart attacks and stroke may be involved in some inflammatory diseases. An in-depth understanding of the role of this receptor in these disease states will aid in identifying novel targets of antithrombotic therapeutics.